CLINICAL TRIAL: ETANERCEPT IN DERMATOMYOSITIS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this study is to determine the safety and tolerability of a medication known as etanercept in patients with DM. Also to see how etanercept and prednisone affect the strength and function of your muscles.